Regulation of Mesenchymal Stem Cell Secretome for Treatment of Microglia Damage in Traumatic Brain Injury

ABSTRACT
The World Health Organization predicts that traumatic brain injury (TBI) will surpass many diseases, including
infectious diseases, as a significant cause of death and disabilities, including significant cognitive dysfunction
and visual impairment. Mesenchymal stem/stromal cell (MSC) therapies have gained considerable attention as
a strategy for protecting against neurodegenerative diseases. However, a poor understanding of the
mechanisms of therapeutic action has hampered their regulatory approval for clinical use. We have pioneered
the therapeutic application of adipose MSC-derived concentrated conditioned media (ASC-CCM), a "secretome"
containing soluble proteins and exosomes, for neurovascular pathologies across a range of preclinical models.
Guided by promising in vivo efficacy data and identification of TNF-Stimulated Gene-6 protein (TSG-6) as an
exosome-cargo protein that suppresses microglial activation, we now propose studies to determine if non-
invasive delivery of ASC-CCM protects against TBI-induced damage. We will test the central hypothesis that
TSG-6 enriched ASC-CCM ameliorates the generation of TBI-induced disease-associated microglia (DAM),
thereby modulating phagocytosis and inflammation to restore the microglial homeostatic state to protect visual
and cognitive function. In Aim 1, using a validated controlled cortical impact model of TBI (CCI-TBI) with and
without intranasal ASC-CCM treatment, we will a) establish the DAM phenotypic correlates of TBI-induced loss
of cognitive and visual functions and b) establish the efficacy of ASC-CCM treatment in TBI. In Aim 2, using
microglia in culture, we will determine if activation of the DAM signature through TYROBP-APOE4-axis signaling
leads to phagocytosis and inflammation and determine how exosomal TSG-6 modulates TYROBP-APOE4-
mediated DAM activation. In Aim 3, we will investigate the hypothesis that exosomes carrying TSG-6 protein are
sufficient to modulate the activation of DAM signature and thus impart the therapeutic benefit in TBI. We will
also study the distribution of exosomes in the tissues and study potential safety and toxicity. The proposed
research is significant and innovative because our expected results would provide the rationale for developing
mechanistically defined regenerative therapies tailored to modulating microglial phenotypes and signaling
pathways involved in neurodegeneration. The PI's laboratories have been engaged for nearly a decade in
developing regenerative and pharmacological therapies for neurotrauma and are well suited to conduct studies
proposed in this application. Our environment at the University of Tennessee Health Science Center and Diadem
Biotherapeutics, Inc makes us uniquely qualified to pursue this objective, given the extensive collective
experience in molecular and stem cell biology, exosome engineering, proinflammatory signaling networks, and
neurotrauma models.

Public health relevance
PROJECT NARRATIVE Public health relevance The proposed research is relevant to public health because traumatic brain injuries are increasing in prevalence, represent a major economic burden, and are major causes of cognitive and vision loss word-wide. The results of our studies will help establish the role of disease-associated microglia in the neurodegenerative process and the potential of refined stem cell therapies to treat such neurodegenerative diseases. Our proposal addresses the current knowledge gap in understanding mechanisms and the potential of cell-based therapies tailored to address traumatic brain injuries.